Core A. Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The present application seeks funding to continue the MIND Institute Intellectual and Developmental
Disabilities Research Center (IDDRC) at the University of California, Davis. The IDDRC was launched in 2013
and is the newest of the 14 IDDRCs in the network. The Administrative Core (Admin Core) provides the
leadership, resources, and support to ensure scientific innovation while accelerating the translation of scientific
discoveries into meaningful changes in quality of life for individuals with IDD and their families. The Admin Core
will address three specific aims. Aim 1 is to support the development and implementation of an impactful,
interdisciplinary, translational research agenda for IDD research. This aim will be addressed by creating an
interdisciplinary leadership team; establishing mechanisms to solicit input from IDDRC investigators, local and
national networks, and the broader scientific community; monitoring progress of IDDRC research, including the
signature research project proposed in this application; and creating “centerness” (i.e., a culture of
interdisciplinary collaboration and team science). Aim 2 is to develop and maintain a robust research
infrastructure to support the translational research agenda of the IDDRC. This aim will be addressed by
developing equitable and efficient procedures for accessing the scientific cores; securing resources to support
and enhance the scientific cores; establishing procedures to ensure that the IDDRC provides high-need, cost-
effective, high-quality core services; and facilitating access to expertise and technologies beyond the IDDRC.
Aim 3 is to encourage innovation in IDD research. This aim will be addressed by encouraging new programs of
research and new methods in the scientific cores; recruiting new investigators into the IDDRC; and supporting a
broad array of educational activities that leverage the unique expertise and resources of the IDDRC and target
scientists at all points in their careers. The Director of the IDDRC and Administrative Core is Leonard Abbeduto,
PhD.